University of Minnesota Summer Research in Neuroscience

PROJECT DESCRIPTION
Disorders of the nervous system are becoming more prevalent in our society, especially
considering the growing elderly population who are more vulnerable to neurodysregulation. To
meet the challenge of developing new and effective therapies to treat these disorders, we need
to consistently inspire intelligent and talented undergraduate students to enter careers in
neuroscience research. This need is particularly acute among populations of students who are
currently underrepresented in the field of neuroscience research. Published analyses have
made it clear that making students aware of research fields early in their college careers,
especially by involving them directly in the research process, is an extremely effective way of
developing a student’s interest in research as a future profession. For over 30 years, the
University of Minnesota has recognized and met this challenge by offering summer residential
research programs in biomedical sciences. This proposal is to fund a neuroscience component
of these summer programs in which we will train 8 undergraduate students who have completed
their freshman or sophomore years in college. We will recruit students nationally, focusing on
students from groups that are underrepresented within the neuroscience research profession,
including economically disadvantaged and disabled students. We will provide them with a 10-
week intensive residential research experience that will include professional mentoring
(academic survival skills and preparation for graduate school) as well as workshops on research
ethics. Our goals are to inspire a new generation of neuroscience researchers as well as to
create a national mentoring pool who will accept that responsibility for future generations of
students. In turn, we expect these individuals to become part of the research infrastructure
dedicated to solving medical problems of nervous system dysfunction.

Public health relevance
PUBLIC HEALTH STATEMENT A major health challenge facing our society is a pervasive range of neurological disorders, which becomes more acute as our population ages. The goal of this project is to continue support of a summer residential research program at the University of Minnesota with the goal of inspiring new generations of bright, talented undergraduate students to enter neuroscience research as a career. The hope is that these future scientists will contribute to the health infrastructure by finding cures for these common, but devastating diseases of the nervous system.